Novel Neurosurgical Device for Evacuation of Intracerebral Hematoma

PROJECT SUMMARY
Spontaneous supratentorial intracerebral hemorrhage (ICH) affects nearly 67,000 patients every year in the
US and is associated with a 35-50% mortality rate within a month of occurrence. In addition to preventive
measures and medical management, surgery continues to be an important part of treatment for such patients.
Currently, removal of ICH from the brain is accomplished through a craniotomy, or large skull opening. For most
large hematomas that come to the surface of the brain, this technique is effective in providing adequate surgical
exposure to remove the mass and to obtain hemostasis. A craniotomy, however, is time consuming and
retraction of the brain during these operations can result in brain injury. Furthermore, large craniotomies can
contribute to postoperative morbidity, such as pain and wound-related complications. Development of less
invasive techniques and methodology will minimize these risks and patient discomfort. Moreover, minimally
invasive techniques may have socio-economic value by reducing operative and postoperative recovery time,
especially for an elderly patient population with multiple medical co-morbidities. Current minimally invasive
technologies, however, result in variable ICH evacuation rates and have limited efficacy in removing deeply
located basal ganglia hematomas. Thus, neurosurgical devices that enable rapid and consistent hematoma
evacuation, irrespective of ICH location, are needed.
The goal of this project is to fabricate and determine the feasibility of a novel instrument (termed “ReMiDe”)
that can efficiently and consistently remove an ICH using image-guided, minimally invasive techniques. Our initial
studies using proof-of-concept prototypes that we designed and fabricated have demonstrated the feasibility of
the approach. Our robotic device creates a cavity in the brain through a <1cm skull opening and is capable of
automatically detaching, fragmenting, cauterizing, and aspirating tissue through a small channel. We have used
live swine models to identify and resolve the mechanical and electrical parameters needed to optimize brain
tissue fragmentation, cautery, and aspiration. Based on our initial designs, we are prepared to generate clinical-
grade prototypes for testing in ICH models. To accomplish this, we propose the following aims:
Aim 1: Design, manufacture, and validate advanced ReMiDe devices.
Aim 2: Evaluate the safety and efficacy of ReMiDe procedure in swine.
Aim 3: Compare the safety and efficacy of ReMiDe to minimally-invasive surgery in the swine ICH model.
The proposed studies are impactful because they will result in the development of a novel instrument that
will enable more consistent, efficient, and less invasive removal of ICH.

Public health relevance
PROJECT NARRATIVE We propose to develop a novel neurosurgical instrument that will enable the rapid and safe removal of brain hematomas. The brain mass can be removed through a small opening in the skull, reducing pain and discomfort compared to current surgical methods requiring a much larger skull opening. Successful development of this instrument will have a direct impact on public health by providing a fast, accessible alternative treatment for hemorrhagic strokes and malignant brain tumors.